Synthetic Chemical Biology Core

PROJECT SUMMARY – CORE C
The Synthetic Chemical Biology Core (SCB) was established in July 2016 from the merger of the Center for
Molecular Analysis of Disease Pathways (CMADP) Molecular Probes Core with the newly established Chemical
Biology of Infectious Disease (CBID) Medicinal Chemistry Core. The synthetic capabilities of the SCB will fulfill
the specific aims of both COBRE centers. The mission for the SCB in Phase 3 is to provide CMADP-affiliated
junior faculty, as well as other investigators in the state of Kansas, with novel molecular probes as
pharmacological tools for in vitro or in vivo elucidation of particular pathways. The SCB will also work towards
achieving self-sustainability beyond Phase 3. The Core will offer expert design and synthesis of small molecule
and peptide molecular probes, with an emphasis on the generation of fluorescent and other affinity tagged
molecules. The SCB will function synergistically with other CMADP-funded Core facilities, including the Genome
Sequencing Core, to identify genes that impact functions of probes in vivo, and the KU Nanofabrication Facility,
to develop devices for imaging and chemical analysis. This integration is designed to empower faculty to use
chemical biology approaches to investigate biological problems.
The specific aims that will be addressed by the SCB in Phase 3 are: (1) Provide enabling small molecules of
interest to COBRE investigators and other clients; (2) Provide synthesis of conventional and specialized peptides
to investigators; (3) Provide outreach, administrative, and fiscal support necessary to manage the above
activities both in the context of COBRE projects and to offer services to the larger Kansas research community
(4) To continue developing a critical mass of core lab users so that the facility becomes a self-sustaining, integral
part of the biomedical research infrastructure in the state of Kansas.